Impact of circadian misalignment on energy balance regulation

The proposed study will test whether the misalignment of eating occasions to the sleep period leads to
positive energy balance and body composition changes. Individuals who sleep and eat late into the day
are at increased risk of obesity and metabolic disorders. This may be due to the activity of neuropeptides that
activate brain reward areas and stimulate food intake, which are also involved in the sleep-wake cycle. We
have shown that sleep restriction activates brain reward areas, such as the insula and orbitofrontal cortex, and
enhances food intake but there is also increasing evidence that eating at the wrong time of day (i.e. during
resting periods in animals or later in the day in humans), may promote weight gain/hinder weight loss.
However, studies of late meal timing are limited to observational studies and confounded by differences in
sleep duration and timing. Since eating is a strong external time keeper, we hypothesize that altering the
alignment of sleep and meal times will cause changes in hormones that regulate energy balance. The goal of
the proposed study is to determine whether eating out of synchrony with sleep has negative consequences for
weight management. The proposed study has both mechanistic and translational objectives. First, we will test
the hypothesis that eating late in the day will promote positive energy balance (mechanistic aims 1 & 2) by
enhancing the rewarding properties of food, altering appetite-regulating hormones, and energy expenditure
compared to eating at earlier times. This will be assessed by measuring neuronal responses to food (functional
magnetic resonance imaging), appetite-regulating hormones (leptin, ghrelin, glucagon-like peptide 1, peptide
YY), and 24-h energy expenditure (metabolic chamber) under controlled feeding conditions. Next, we will test
the hypothesis that 4 wk of free-living conditions of misaligned meals, relative to aligned meals, will lead to
increases in energy intake and body fat (translational aim 3). Forty-four overweight men and women will be
recruited to participate in a 2-phase, crossover study, with constant sleep periods. Phases will only differ in the
alignment of meals to the sleep period: aligned = meals starting 1 h after awakening; misaligned = meals
starting 5 h after awakening. Mechanistic aims will be addressed from measurements taken after 3 and 14 d of
the intervention. Blood samples will be assayed for melatonin and cortisol as markers of circadian rhythm. The
translational aim will be addressed after a 4 wk free-living period following the prescribed meal times for each
phase. This proposed study, which will manipulate meal timing, without affecting total sleep time, is important
because it will provide information on the mechanism by which circadian misalignment influences obesity risk,
independent of sleep duration. It will also provide information to help explain the greater prevalence of obesity
in shift workers, those affected by jetlag/social jetlag, and breakfast skippers. As such, the proposed study will
be a stepping-stone in the establishment of lifestyle recommendations or therapies to personalize chronotype
to improve weight management and cardio-metabolic risk reduction.

Public health relevance
Preliminary findings from our lab suggest that circadian misalignment, occurring when meals and sleep are mistimed from one another, alters resting state neuronal processing in areas relevant to food reward and interoception; supporting a role of sleep and meal misalignment, on energy balance regulation. No study has been done to disentangle the effects of sleep and meal timing on body weight regulation, independent of sleep duration. This study will provide information to guide messaging related to timing of meals and sleep that can be translated to individuals whose sleep follows unconventional times, such as shift workers and those with jetlag and social jetlag.